Midwest Consortium for Hazardous Waste Worker Training

PROJECT SUMMARY/ABSTRACT
The Midwest Consortium for Hazardous Waste Worker Training (MWC) provides model training programs
to workers and residents who may be exposed to hazardous substances. This programming is delivered by 13
training centers in 9 states: Illinois, Indiana, Kentucky, Michigan, Minnesota, North Dakota, Ohio, Tennessee,
and Wisconsin. Eight of the centers are equipment-based centers that focus most strongly on HAZWOPER
and related training for workers at designated hazardous waste sites; treatment, storage, and disposal
facilities; and in a broad range of emergency response roles. The five remaining centers are community-based
centers that focus on helping workers and residents, particularly those from underserved populations, to
recognize and react to hazardous materials in their communities.
Of the 9 MWC states, 5 (Illinois, Kentucky, Minnesota, North Dakota, Tennessee) were impacted severely
enough by weather-related events during 2022 that disasters were declared according to the U.S. Federal
Emergency Management Agency (FEMA). Five of the MWC training centers in the affected states are able to
provide training with proposed supplemental funding: the Three Affiliated Tribes in North Dakota, the University
of Illinois, the University of Minnesota, the University of Tennessee, and YouthBuild Louisville in Kentucky. The
MWC has developed a variety of curricula to support disaster preparedness, response, and recovery training.
Training delivery with these curricula will lead to emergency responders, government workers, community
members, and others being better prepared for future storms and other disasters.
From August 1, 2023 to May 31, 2025, the MWC proposes to deliver 81 programs to 1,286 participants for
a total of 6,020 contact hours in the 5 states in which disasters were declared in 2022. Programs will be
evaluated using the MWC's standard procedures. Each program delivered will be recorded in the NIEHS
Worker Training Program Data Management System. Progress on training supported by this supplemental
funding will be detailed in the MWC's annual interim and final reports. Participants from economically
vulnerable populations and populations underrepresented in hazardous materials training will be key
audiences for the proposed training. The training will provide substantial service to workers and community
members in the Midwest who were affected by disasters in 2022.

Public health relevance
PROJECT NARRATIVE The Midwest Consortium for Hazardous Waste Worker Training facilitates adult-based, action-oriented, results-centered worker and community training with the goal that participants will better recognize and manage risks of occupational and environmental exposure to hazardous materials and waste in nine states. Five of these states (Illinois, Kentucky, Minnesota, North Dakota, Tennessee) were impacted severely enough by weather-related events during 2022 that disasters were declared according to the U.S. Federal Emergency Management Agency. With supplemental funding, the Midwest Consortium proposes to deliver training to vulnerable populations in these five states to provide emergency responders, other workers, and community members with knowledge and skills to prepare for, respond to, and recover from weather-related disasters.